Mechanisms of SFG Rickettsia-Host Interactions

PROJECT SUMMARY/ABSTRACT
Spotted Fever Group (SFG) Rickettsia species are obligate intracellular bacterial pathogens that cause mild-to-
life-threatening vascular diseases in humans. To promote widespread disease, SFG Rickettsia species have
evolved dynamic strategies to invade host cells, escape into and thrive within the cytosol, and spread from cell
to cell. We hypothesize that SFG Rickettsia coordinate their complex life cycle by delivering an arsenal of
secreted bacterial proteins (i.e., effectors) into cells to reprogram cellular processes, but the identity and targets
of these secreted effectors have remained largely unknown. Furthermore, how these effectors function in the
vector are a mystery. To overcome these barriers, we have used a forward genetic screen and cell-selective
proteomics to identify and study secreted effectors. We discovered that the effector Sca4 promotes cell-to-cell
spread in mammalian cells in contrast to its critical role regulating bacterial growth in tick cells. Each of these
activities have been linked to distinct adhesion and endocytic machinery, respectively, highlighting the different
contributions effectors play across environments. Then, using a bioorthogonal non-canonical amino acid tagging
strategy for the first time in the Rickettsia genus, we also discovered seven new effectors we called Secreted
rickettsia factors (Srfs). Most of these Srfs are annotated as hypothetical proteins and localize to distinct
subcellular compartments in host cells. This proposal will leverage these key discoveries alongside our
multidisciplinary approaches in cell biology, biochemistry, and genetics to examine how secreted effectors
promote different aspects of the R. parkeri infectious life cycle. In Aim 1, we will investigate the functions of Sca4
across cellular environments to elucidate how Sca4 specifically targets the subcellular pool of a host cell-cell
adhesion factor during R. parkeri cell-to-cell spread (Aim 1.1) and how Sca4 promotes bacterial growth in tick
cells (Aim 1.2). In Aim 1.3 we will ask if these functions are also required in in vivo models of infection, highlighting
critical functions of Sca4 in mammalian and tick colonization and pathogenicity. Then in Aim 2, we will use high-
throughput phenotypic and interactome screens to begin to dissect the functions of the novel Srfs. Collectively,
the proposed research will dramatically improve our fundamental understanding of rickettsia biology and
rickettsia-host/vector interactions, which is essential to combat the growing threat of tickborne diseases.

Public health relevance
PROJECT NARRATIVE Rickettsia species are intracellular bacterial pathogens that cause mild to deadly vascular diseases in humans. Our overall goal in this project is to determine how secreted bacterial proteins hijack host cell function to promote pathogenesis. This work will enhance our understanding of Rickettsia pathogenesis across mammalian and arthropod environments, which may lead to improved diagnostics or therapeutics.